Discovering modulators of exonucleases PLD3 and PLD4 for immunoregulation

ABSTRACT
Previously thought to be phospholipases, PLD3 and PLD4 have recently been revealed to be endosomal
exonucleases that regulate the innate immune response by digesting the ligands of nucleic acid sensors. These
enzymes can suppress RNA and DNA innate immune sensors like TLR7-9, TLR13 and an unknown STING
sensor. Cells deficient in PLD3 or PLD4 have enhanced responses to certain ligands of TLR9. Additionally, Pld4–
/– mice overproduce cytokines and upregulate major histocompatibility complex class II on the surface of resident
peritoneal macrophages. These responses are unsurprising considering the powerful immunomodulatory effects
of nucleic acid ligands on B cell, macrophages, and dendritic cells, particularly plasmacytoid dendritic cells, which
produce significant quantities of type I interferon (IFN). The recently discovered immunoregulatory role of these
enzymes helps explain the correlation between their polymorphisms and diseases like rheumatoid arthritis,
systemic sclerosis, Alzheimer’s disease, Kidney Fibrosis, and other inflammatory diseases. In addition to
therapeutics for these diseases, modulators of PLD3 and PLD4 may serve as adjuvants, stabilizers of
oligonucleotide therapies, and immune suppressants and stimulators.
Nucleic acid sensors agonists are highly sought with several compounds that target TLRs and STING pathways
undergoing undergoing clinical trials as adjuvants for immune responses to cancer and in other vaccines.
Imiquimod demonstrates the feasibility of targeting TLRs and is approved for use in humans for the treatment of
actinic keratosis, genital warts and non-melanoma skin cancers. PLD3 and PLD4 modulators present a unique
strategy of targeting nucleic acid sensors for two reasons. (1) Rather than target specific sensors, PLD3 and
PLD4 modulators would affect the availability of the nucleic acid ligands of several immune sensors. (2) Due
differences in cell type expression, PLD4 modulators would allow for selective targeting of immune cells as
opposed to the boarder effects of PLD3 modulators. To realize any promising therapeutic potential, PLD3 and
PLD4 pathways, and their role in disease, must be defined. To this end, we seek to identify small molecule
probes that selectively and nonselectively activate or inhibitor PLD3 and PLD4.
We have developed a high-throughput fluorescence enzymatic activity assay to identify modulators of PLD3 and
PLD4 function. A pilot screen of a diversity library (N = 1056) has identified nonselective and selective activators
and inhibitors of PLD3 and PLD4. We seek to explore a broader chemical space by screening a ~100K diversity
library. With these data, structural activity relationships will be identified and explored through medicinal
chemistry. Cell assays to assess potency, specificity, and toxicity will be employed to vet hits. Finally, binding
kinetics, protein isoform activity, and in vitro chemical stability will be evaluated to guide optimization of probe
molecules for mouse models.

Public health relevance
NARRATIVE PLD3 and PLD4 are implicated in a variety of inflammatory diseases and have recently been revealed to be immunoregulatory endosomal exonucleases that regulate innate immune sensors of RNA and DNA, including TLR7-9, TLR13 and an unknown STING sensor. We have developed a high-throughput fluorescence enzymatic activity assay to identify modulators of PLD3 and PLD4 function. We seek to deploy this assay to identify selective and nonselective activators (immunosuppressants) and inhibitors (immunostimulators) of PLD3 and PLD4 and optimize them for application as in vivo probes to better understand the roles of these proteins in disease.